Dichotomy of HIV-Sugar with Vaginal Microbes

PROJECT SUMMARY
This proposal is built upon a novel discovery from the PI Mak laboratory showing that a ‘non-electrostatic,
specific, manipulatable, sugar-sugar’ is an attachment factor for HIV. This interaction occurs between HIV
oligomannose (oligoman) and cellular N-acetylglucosamine (GlcNAc) prior to receptor engagement. The
conservation of glycan biology across domains of life and the non-living (viruses) has led to our current proposal
to investigate whether this oligoman-GlcNAc (or oligoman-based) interaction may underpin some of the dynamic-
interplays amongst: (i) vaginal microbes; (ii) HIV; and (iii) their human host. Our findings that HIV double up to
use its oligoman enriched HIV envelope (Env) glycan shield as an attachment factor may offer a general principle
to account, at least in part, for: (i) how vaginal lactobacillus offers protection from HIV transmission; and (ii) how
vaginal Neisseria gonorrhoeae increases the risk of HIV transmission. As many vaginal microbes have mannose-
binding proteins and GlcNAc on their bacterial surface, our hypothesis is that the enrichment of oligoman N-
glycans on HIV Env acts as a molecular Velcro to interact with mannose-binding proteins and/or GlcNAc sugars
on the surface of genital microbes. We further hypothesize that the biology of these genital microbes would
either helps trap HIV to deny their access to infect the host or acts as a courier service to deliver HIV into the
host. We will use a combination of ultrastructural imaging techniques, biophysical approaches, molecular virology
techniques, cytometry by time of flight (CyTOF) -imaging, glycan matrix-assisted laser desorption ionization -
mass spectrometry imaging (MALDI-MSI), and tissue culture-based epithelial cell model system to examine the
transmission of HIV via oligoman-based binding via two specific aims. In Aim1, we will define whether vaginal
lactobacillus limits HIV transmission via oligoman-based trapping. In Aim2, we will assess if HIV hitch-hike across
sub-epithelial barrier via oligoman-mediated bindings with N.gonorrhoeae. Successful completion of this
proposal may result in proof of concept data that a simple oligoman-based mechanism could account for the
opposing abilities of how lactobacillus protect and how N.gonorrhoeae enhance HIV transmission, respectively.
We will also use pre-set vaginal microbes reference population from ATCC to evaluate these glycan-based
interaction at the population level. We will perform follow-up analyses with vaginal microbiomes derived from
established and clinically relevant South African HIV cohort. Data showing oligoman-based interaction is a
contributing factor to sexual transmission of HIV may offer new hope for the development of a practical, orally
delivery self-administrated HIV mitigation strategy using optimised versions of GlcNAc or mannose, given these
parental monosaccharides are widely available, non-toxic, off-the counter, nutraceuticals.

Public health relevance
PROJECT NARRATIVE Trauma and/or inflammation as mechanisms cannot fully account for the different HIV transmission rates in the presence of specific genital microbes. We have recently shown that HIV glycan shield double-up as an attachment factor via a novel ‘non-electrostatic and specific’ oligomannose (oligoman)-based interaction, offering a general mechanism to account for the opposite HIV transmission phenotypes seen in the presence of lactobacillus vs sexual transmission infection bacteria, such as Neisseria gonorrhoeae. This project will determine whether this manipulatable oligoman-based interaction has: (i) helped trapped HIV onto lactobacillus to reduce HIV transmission; and (ii) allowed HIV to hijack Neisseria gonorrhoeae to gain access into the host.